Repurposing momelotinib for the prevention of aminoglycoside-induced ototoxicity

PROJECT SUMMARY:
Aminoglycoside antibiotics are considered an essential group of medications by the World Health Organization.
Each year, thousands of children and adults are prescribed aminoglycosides to treat severe gram-negative
bacterial infections. This is especially prominent in the neonatal intensive care units, where over 80% of the
neonates are prescribed aminoglycosides. Unfortunately, administration of aminoglycosides carries substantial
risk for life altering side effects, namely irreversible hearing loss. This is especially evident in the fact that 15 out
of every 100 neonates will experience hearing loss, as compared to the 1 to 3 out of every 1,000 babies who are
born full term. Hearing loss alters an individual’s ability to communicate and is associated with feelings of isolation
and depression. Substantial effort is still required to identify the first FDA approved therapeutic for prevention of
aminoglycoside related ototoxicity. We are proposing this study with the long-term goal of providing a therapeutic
to combat this ototoxic side effect. To date, we have collected promising preliminary data suggesting
momelotinib, a drug currently with FDA fast track designation, could be repurposed for this use. In Aim 1, we
will use an aminoglycoside treated sepsis mouse model to provide preclinical, functional hearing data on the
ability of momelotinib to prevent aminoglycoside induced hearing loss. In our experiments proposed in Aim 2,
we will utilize the well-established and translatable zebrafish model organism to identify the essential targets and
mechanisms of hair cell protection by momelotinib. This project advances the mission of the NIDCD to promote
interventions to treat communication and other disorders. Specifically, our mechanistic studies in Aim 2 address
Priority Area 2 in Hearing and Balance Research to increase the understanding and pathogenesis of ototoxicity.
In addition, our characterization of momelotinib as a promising preventative treatment for aminoglycoside
induced hearing loss advances Priority Area 3, to improve the diagnosis, treatment, and prevention of hearing
loss through the development therapies to resist cell damage. This project will be completed at Creighton
University under the sponsorship of the well-established auditory scientist, Dr. Jian Zuo. Creighton University
has a strong history of auditory research. It houses a Translational Hearing Center dedicated to research pursuits
in the therapeutic prevention of hearing loss and hearing restoration through hair cell regeneration. The
physician-scientist program at Creighton University provides a well-rounded, integrated curriculum and tailors
educational and clinical experiences to each student and their career aspirations. Specifically, the gateway
program and longitudinal clinic provide great opportunities for students to gain exposure to the field they are
going to enter. There is also a clinical refresher course offered during the last year of research training, which
will ease the transition of the students back into the clinic. Overall, the strong auditory research community,
unique training environment and impactful research project, ensures that my time at Creighton University will
facilitate my development to become an independent physician-scientist in the field of otolaryngology.

Public health relevance
PROJECT NARRATIVE: Aminoglycosides represent an indispensable class of antibiotics that have saved countless lives from severe bacterial infections however, their use is associated with several adverse effects including irreversible hearing loss. In this study, we will investigate momelotinib, a potential therapeutic for aminoglycoside induced hearing loss, as well as investigate the specific molecular targets of the drug that results in the prevention of hearing loss through the protection of sensory hair cells. This study will provide necessary preclinical data for this promising drug candidate to be used to prevent aminoglycoside induced hearing loss.